Molecular Mechanisms of Mitochondrial Transcription and Replication

PROJECT SUMMARY
Multiple debilitating disorders, such as myopathies, hearing and vision loss, are the result of defects in
mitochondrial DNA (mtDNA) replication and transcription. The driving forces behind these essential processes
in human mitochondria are two Pol A family polymerases – RNA polymerase mtRNAP and DNA polymerase
Gamma, Polg. Structures of the macromolecular machines formed by these enzymes are the main focus of this
proposal. We will investigate how mtRNAP recruits transcription factors, recognizes, binds, and melts promoter
DNA, and initiates RNA synthesis using single-particle CryoEM. Because transcription generates DNA
supercoiling, interactions of the transcription elongation complex with mitochondrial topoisomerase will be
probed using function assays, cross-linking, and CryoEM. We will also determine the structure of replicative
helicase, TWINKLE, in a complex with a fork template to elucidate the mechanism of DNA strand separation.
The structure of a replisome – the complex of Polg with TWINKLE formed on a fork template – will be determined
by CryoEM to elucidate the mechanism of mtDNA replication. Replication initiation at replication origin OriL
requires an interplay between mtRNAP, which generates ~30 nt replication primer, and Polg. Two polymerases
form a primosome complex on the OriL hairpin, the structure of which will be probed by CryoEM. Studies of the
structure and function of the transcription and replication machinery are critical for understanding the regulation
of mitochondrial genome expression. This, in turn, will determine our ability to influence various mitochondrial
functions and, consequently, treat mitochondria-associated diseases.
Human mtDNA is highly prone to somatic mutations, including point mutations and deletions, which are
detrimental to mitochondrial function and cell viability. It has been found that aging mammals have increased
levels of somatic mtDNA mutations, however, the biochemical mechanisms underlying the formation of mtDNA
mutations and mtDNA maintenance are poorly understood. Biochemical and structural approaches will be used
to fill in the large gap of knowledge associated with DNA repair in human mitochondria. This work will examine
the process of proofreading by Polg using CryoEM to determine the structural basis of this mechanism. DNA
repair complexes will be reconstituted using Polg and known DNA repair proteins, and their structures determined
using CryoEM. Additional interaction partners of Polg that are involved in DNA repair will be identified using
pulldown assays and mass spectrometry, and their activity will be probed using functional assays. We will also
investigate transcription-coupled repair mechanisms by reconstituting transcription complexes on DNA scaffolds
containing UV damage and determine their structure. Factors involved in DNA repair will be identified using
pulldown assays from UV-treated cells and their complexes with mtRNAP subjected to CryoEM. The research
described in this proposal will provide valuable knowledge pertaining to the onset of degenerative mitochondrial
diseases.

Public health relevance
PROJECT NARRATIVE The accumulation of somatic mutations in mitochondrial DNA has been associated with many degenerative diseases and is known to promote aging, however, the biochemical mechanisms underlying the formation of mutations are not well defined. This research will provide insight into the molecular mechanisms underlying faithful mitochondrial DNA replication and repair by determining the structure and function of the human mitochondrial replication and transcription machinery during different stages of replication.